Six-Dimensional Single-Molecule Nanoscopy for Elucidating the Dynamic Organization of Biomolecules

7. PROJECT SUMMARY
The goal of the proposed MIRA-funded research portfolio is to discover how dynamic interactions between
individual biomolecules at the nanoscale influence their collective function and organization in complex
biophysical processes. The proposed research program integrates continued development of 6D single-
molecule (SM) imaging (3D positions and 3D orientations) with mechanistic studies of the organization of
biomolecular interactions at the nanoscale. Importantly, the proposed scientific goals synergistically spur the
development of impactful imaging capabilities, and these new capabilities will in-turn overcome barriers to enable
novel significant scientific trajectories to be pursued. Four broad research thrusts will be pursued.
Thrust 1 will develop smart adaptive 6D nanoscopy. Previous studies have shown that fixed imaging systems
cannot measure all possible molecular rotational motions with the best-possible quantum-limited precision. Thus,
dynamic illumination and fluorescence modulation hardware will be integrated to enable the imaging system to
adapt as data is collected. Fusing model-driven design algorithms with data-driven deep learning methods will
yield smart microscopes that enable measurements that are not possible even with current state-of-the-art
nanoscopes. Thrust 2 will develop high-speed 6D SM tracking to map spatial heterogeneities in molecular
interactions between biomolecules. These heterogeneities govern important processes like phase separation,
but current techniques have sufficient spatiotemporal resolution to resolve mechanistic details. Time-varying
illumination, single-photon counting, and direct pupil imaging will be integrated to visualize these dynamics using
10x fewer emission photons and thus 10x faster speed than state-of-the art methods.
Thrust 3 will leverage developments in 6D nanoscopy to elucidate dynamic molecular architectures of self-
assembling peptides and natural amyloidogenic proteins. Critically, scientists must disentangle the effects of
peptide sequence, secondary structure, assembly architecture, and aggregation conditions to create new
biomaterials for diagnostics and therapeutics, as well as to elucidate the mechanisms of cytotoxicity in amyloid
diseases. The 6D positions and orientations of transiently binding fluorophores will visualize the dynamic
organization of individual peptide assemblies both in vitro and as they interact with living cells with nanoscale
resolution. Thrust 4 will leverage developments in 6D SM tracking to visualize heterogeneous network
architectures within biomolecular condensates that ensemble measurements fail to detect. The 6D positions and
orientations of fluorogenic probes will be used to characterize the network architecture of stickers and spacers
within the condensate, thereby visualizing the driving forces of phase separation. Six-dimensional SM nanoscopy
will also directly observe how proteins are recruited and reorganized throughout the phase separation process,
leading to mechanistic insights into the formation and spatiotemporal evolution of biomolecular condensates.

Public health relevance
8. PROJECT NARRATIVE Interactions between proteins and nucleic acids give rise to self-assembly and phase separation that directly impact gene regulation, cell-cell signaling, and amyloid aggregation. This research will develop new technologies to visualize the motions, organization, and interactions of these biomolecules at the molecular level. These technologies will be an invaluable tool in the study of the mechanisms of Alzheimer’s disease and amyotrophic lateral sclerosis (ALS).